RESIDENTIAL TREATMENT OUTCOMES OF PATIENTS WITH INSULIN DEPENDENT DIABETES

The purpose of this study is to determine if residential treatment can result in improved diabetes control and coping skills. This is a DSL-only protocol.